United for Health Equity - Living PDX Program (U4HELPP)

PROJECT SUMMARY/ABSTRACT – OVERALL
The United for Health Equity-Living PDX Program (U4HELPP) seeks to develop >500 new patient-derived
xenograft (PDX) models of cancers originated from the breast, pancreas, colon, liver, lung, and other advanced
peritoneal cancers. These PDXs will be made from >60% of patients from underrepresented populations which
our safety-net clinical system serves. To develop such a large number and diverse set of PDXs, we have enlisted
the support of a set of surgeons that specialize in each cancer type. Once extracted, the tumors are immediately
provided to the U4HELPP PDX Core which functions to propagate, distribute, and cryopreserve them.
Successfully generated PDXs will be subjected to genomic characterization and quantitative ancestral profiling
by the U4HELPP Bioinformatics Core so that we can better understand how ancestry contributes to genetics
and responses to targeted therapeutics. The PDXs will be provided to two Research Projects, that will focus on
either pancreatic cancer or breast cancer. The Pancreatic Cancer project will generate large-scale proteomics
insights from over 200 PDXs to refine subtypes of the disease and identify more effective therapeutics from Black
and White patients. The Breast Cancer project will utilize 20 PDXs that are Basal-like breast cancers,
characterize their metastatic profiles, define proteogenomic pathways that mediate metastatic growth, and target
metastases with synergistic investigational new drug combinations. The information from these PDXs and
Projects will be shared with the U4HELPP Pilot Projects and Trans-Network Activities Core which will award Pilot
Project grants to utilize the PDXs generated by us and our partnering PDXNet institutions. All of the PDXs and
insights gained will be shared with the NCI with the goal of reducing cancer disparities. Through this team effort
we are confident that we will be able to develop these unique resources and generate significant preliminary
data that will support investigator initiated clinical trials at the Massey Cancer Center.

Public health relevance
Narrative The United for Health Equity-Living PDX Program (U4HELPP) seeks to develop, characterize and test >500 new patient-derived xenograft (PDX) models from underrepresented patient populations such that our research studies can more adequately represent the diverse patient population that our cancer center serves.